Administrative Core A

Project Summary Core A – Administrative Core
The CWRU Center for Excellence on the Impact of Substance Use on HIV Administrative
Core is responsible for driving the direction of Substance Use in HIV research at our institutions
by being responsive to the evolving research needs of Center investigators. The Administrative
Core provides the leadership and organizational structure to coordinate, support, and enhance
the efforts of the Center members and bears responsibility for the scientiﬁc, administrative,
budgetary, and operational aspects of the Center. The major strengths of the Center include
scientific and technological innovation and expertise to pursue our four main objectives in
studying the impact of Substance Use on HIV:
(i) Methamphetamine & HIV and immunosuppression on neurocognitive impairment,
due to glial activation, oxidative stress, astrocyte gliosis, neuroinflammation, and HIV
reactivation.
(ii) Cocaine & HIV dysregulation of the fronto-striatal dopamine circuit in microglia,
driving the progression of motivational dysfunction and increasing susceptibility to
HIV and favoring HIV replication and latency.
(iii) Opioid & HIV modulation of viral replication, virus-mediated pathology, blood-brain-
barrier, immunosuppression, viral latency, and viral rebound.
(iv) Hormetic effect of Cannabis & HIV, as anti-inflammatory at low doses, limiting HIV
viral replication and attenuating HIV-related immunosuppression and inflammation,
and at high or chronic doses, associating with reduced gray matter volume and
memory deficits.
The Administrative Core A has developed a forward-looking Strategic Planning process that
includes input from Center members and leadership, as well as institutional administrative
personnel. Implementation of the Strategic Plan includes (a) organizing, managing, and
advertising the Research Support Cores, (b) obtaining and effectively using institutional funds to
further invest in junior and underrepresented investigators in medicine with novel research
programs in a team science setting, (c) exercise fiscal constraint and advance external funding,
(d) develop educational, policy, and outreach activities that fully engage Center investigators
and local departments of publish health, and (e) fairly apply well-publicized, agreed upon
evaluations. The Specific Aims for the Center Administrative Core A are:
• To coordinate and implement a rigorous annual review and strategic planning process.
• To leverage institutional support to enhance Substance Use research at our institutions.
• To support our significant footprint in systems biology and ‘big data’ collection,
management, storage, and analysis.
• To stimulate training, educational, and community outreach activities throughout the
Center for Excellence.
• To improve communications throughout the Center and oversee responsible, rigorous,
and reproducible research activities.
• To serve as national research resource in the drug use in HIV research field.

Public health relevance
Project Narrative – Administrative Core A Substance use remains the second most common mode of exposure to HIV among infected individuals nationwide, representing 31% of total diagnoses. In addition, substance use is associated with a more severe course of HIV disease as shown by poor immune reconstitution and increased rate of co-morbidities. This core provides administrative support to the CWRU Center for Excellence.